3D Models of the Blood-Brain Barrier for Studying Trauma-Induced Cerebral and Systemic Injuries

Abstract
Traumatic brain injury (TBI) and Alzheimer's disease (AD) are two devastating neurological disorders with a
complex relationship. Studies have shown that patients with a history of moderate or severe TBI have a two
to four-fold increased risk of developing AD compared to those with no history of head injury. The
mechanistic link between two disorders is not well understood. Both diseases show cerebrovascular
dysfunction, which would be a causal link between TBI and the subsequent development of vascular
dementia and AD. Patients with TBI suffer initial acute injuries, which disrupts the structural integrity of the
brain and brain vasculature. Such disruption leads to further breakdown of the blood brain barrier (BBB).
Studies of postmortem brains of TBI showed diffuse amyloid beta (Aβ) plaques in autopsies after acute
injuries. It appears that TBI-induced neurovascular injuries could accelerate production and perivascular
accumulation of amyloid-beta (Aβ), leading to blood brain barrier damage and inducing a deleterious feed-
forward loop. However, it is still unclear which mechanisms lead to Aβ accumulation in TBI. We hypothesize
that vascular leakage and exposure to plasma factors induce the increased production of Aβ in neurons and
decreased clearance of Aβ from neurovascular niche. In this supplement, we propose a complementary
project to study the consequent effect of vascular disruption on neuronal cell function and identify the role of
plasma factors on Aβ production from neuronal cells in brain organoids we differentiation from hiPSCs. We
will perform these experiments in isolated organoids and in organoids co-cultured at the vascular interface.
We will identify how plasma factors of TBI patients affect Aβ production hiPSC-derived neurons. We will
also establish a BBB model comprised of vascularized brain organoids and evaluate the role of vascular
dysfunction on Aβ deposition and accumulation around the BBB. The success of the project will provide
important information in mechanistic link between the TBI and initiation of AD, and will have numerous
implications in future neurovascular engineering approaches and therapeutic development to prevent TBI
induced AD.

Public health relevance
Project Narrative Traumatic brain injury (TBI) and Alzheimer's disease (AD) are two devastating neurological disorders with a complex relationship and cerebrovascular dysfunction may serve as a mechanistic link between the two disorders. In this supplement, we propose a complementary project to study the consequences of TBI induced vascular disruption on neuronal cell function and identify the role of plasma factors on Aβ production from neuronal cells in brain organoids. We will perform these experiments in isolated organoids and in organoids co-cultured at the vascular interface.